Planning and Evaluation Core (PEC)

Planning and Evaluation Core
The Planning and Evaluation Core (PEC) is comprised of the Partnership’s Administrative Core, Internal Advisory
Committee, Program Steering Committee, Executive Committee and external evaluator to provide oversight of
the overall Partnership activities and programs. It will be responsible for all aspects of planning, monitoring,
evaluation, and tracking of Partnership Translational Cancer Research for Health Equity activities. In addition,
this core serves as a platform from which the Partnership’s PIs can discuss strategic plans that can move the
U54 Partnership towards new initiatives that strengthen the goals and mission of both institutions. The PEC
specific goals and objectives are: 1) In collaboration with the Administrative Core, the Partnership PIs (Drs.
Ahles, Gany, Hubbard and Vuong) with the Internal Advisory Committee and the Program Steering Committee,
will work to ensure ongoing planning, monitoring, evaluation and tracking of Partnership activities including: a.
Coordination and management of the solicitation of new research proposals; b. Review and selection of Pre-
Pilot, Pilot, and Full Projects for funding, monitoring of project progress, and decision-making regarding
discontinuation of funding for projects not meeting goals; c. Development of new initiatives based on
opportunities presented on a national level (e.g., Blue Ribbon priorities, RFAs and PARs issued) or at either
institution; d. Identification of faculty searches that are potentially synergistic with Partnership goals; 2) To use
mixed method approaches to monitor and evaluate all aspects of Partnership functioning, in collaboration with
the external evaluator, Dr. Robin Isserles, to: a. Track pertinent data that monitors and assesses the
Partnership’s goals and objectives, such as publications and grant submissions by investigators, student tracking
data, and community outreach assessments; b. Review all aspects of Research Project development and
implementation; c. Evaluate all aspects of the proposed educational programs implemented through the
Research Education Core (REC); d. Utilize the RE-AIM framework to monitor and evaluate all aspects of the
proposed Partnership Community Outreach, Research, Education/Engagement Core (PCORE) activities; e.
Ensure that the Linguistic and Cultural Responsiveness Shared Resource Core (LCRSRC) meets target metrics,
also guided by the RE-AIM framework; f. Record, monitor, and assess all administrative support activities,
resources, and programmatic integration measures, and, in concert with the Administrative Core, track and
monitor short- and long-term impacts of the Partnership.

Public health relevance
As per solicitation PAR-23-308 Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE) (U54 Clinical Trial Optional) Project Narrative: Do not complete